Exploring the Dynamics of Prolyl-tRNA Synthetases: Towards Developing a Screening Method for Species-Specific Inhibitors

Broadly speaking, our research group studies the interplay between enzyme dynamics and
catalysis. This supplemental proposal is developed to acquire Isothermal Titration Calorimeter,
which will aid in investigating the effects of molecular crowding on enzyme structure-dynamics-
functions. The interior of a cell is extremely crowded, which can potentially impact protein
properties such as structure, folding, stability, ligand binding, and enzyme catalysis. The crowding
effects could mediate through hard/steric/entropic and/or soft/chemical/enthalpic interactions. Our
objective is to investigate the exact mechanism of crowding/confinement and their impacts on
substrate binding and catalysis. We are studying the multidomain prolyl-tRNA synthetases
(ProRSs), which play a vital role in protein synthesis in all living organisms. Earlier, we
demonstrated that domain dynamics is central to ProRSs functions, which are impacted by the
crowder-induced shift in the conformational ensemble. Currently, the impact of the “uniform
crowding environment” (nonprotein-based crowders) and “structured crowding environment”
(protein-based crowders) on conformational dynamics and function of Escherichia coli (Ec) ProRS
is being probed. The mechanistic implications of crowding and confinement effects are significant
as these enzymes are promising anti-microbial drug targets. The conformational change and
crowder-enzyme interactions are being probed by fluorescence spectroscopy, molecular
dynamics simulations, and small molecule docking studies, while varying the size, shape,
chemical nature, and concentration of the crowders. We are examining the role of molecular
crowders on the substrate binding using Saturation Transfer Difference - Nuclear Magnetic
Resonance, which requires a large quantity of proteins and kinetics parameters are obtained from
enzyme kinetics assays using radiolabeled substrates. The isothermal titration calorimetry (ITC)
method is a label-free direct measurement of the heat evolved or absorbed during a binding event
between interacting molecules and enzyme-catalyzed reactions and requires less sample. ITC
experiments provide the thermodynamic profiles, which would enable us to establish the
molecular mechanism of crowding and confinement resulting in enzyme's altered function. A
detailed understanding of crowding effects on the properties of multidomain proteins like Ec
ProRS could open up new possibilities for protein designing and drug discovery. Moreover, the
ITC equipment would enable us to provide hands-on experiences to students in biochemistry and
biophysical chemistry courses (~25 students/semester) by designing course-embedded research
projects on calorimetry and teaching them the ligand binding thermodynamics in drug discovery.

Public health relevance
RESEARCH STRATEGY Because of their central role in protein synthesis, aminoacyl-tRNA synthetases (AARSs) have emerged as attractive targets for anti-infective drug development. Despite significant differences among the protein sequences and the structural architecture (between the pathogens and the host AARSs), most of these enzymes share some similarities in substrate recognition and binding; therefore, drugs that are developed based on static models of the targeted sites of the pathogenic AARSs are often associated with toxic side effects. In the proposed work, a proper characterization of the interplay of intrinsic dynamics and molecular recognition/catalysis of an AARS will be made with a hope to develop a species-specific inhibitor screening model based on the protein's intrinsic flexibility.